A platelet-fibroblast axis connecting bioenergetics and metabolism in SSc-pulmonary arterial hypertension

Pulmonary arterial hypertension (PAH) is a deadly disease associated with systemic sclerosis (SSc-PAH)
and is dependent on several vascular cell types. However, key systems of molecular cross-talk remain
enigmatic. Previously, we defined a key regulatory axis between the transcriptional coactivators YAP/TAZ with
the enzyme glutaminase, establishing a new paradigm of how glutamine metabolism is related to vascular
stiffness in PAH. Yet, crucial questions remain. What are the triggers that activate YAP/TAZ to initiate PAH and
do they originate from separate cell types? Downstream of those triggers, can vascular glutamine metabolism
serve as a diagnostic indicator of SSc-PAH? Our unpublished data demonstrate that platelets from SSc patients
show dysregulated mitochondrial energetics which correlate with the severity of vascular manifestations in these
patients and cause increased glutaminolysis in pulmonary adventitial fibroblasts. Hypothesis: Altered platelet
energetics signal to PA fibroblasts, resulting in specific alterations of glutamine metabolism to control
collagen deposition, vascular stiffness, and SSc-PAH. In this translational proposal, we will define the
presence of dysregulated platelet energetics and fibroblast glutamine metabolism in SSc-PAH. We will also
determine if fibroblast glutamine uptake can be targeted for the development of more effective diagnostics. Aim
1) Determine whether dysregulated platelet energetics is associated with the severity of vascular
symptoms in SSc and with lung vascular fibroblast glutaminolysis in SSc-PAH. We postulate that
dysfunctional platelet energetics can serve as a biomarker of progressive vascular damage in SSc and is
associated with increased glutaminolysis in pulmonary adventitial fibroblasts in SSc-PAH. To investigate,
platelets will be isolated from SSc-PAH, SSc, and control patients and energetic profiles will be analyzed and
correlated with measures of clinical vascular measures. In parallel, single cell RNA sequencing of human SSc-
PAH vs. control explant lungs will determine if platelet energetic transcriptional profiles correlate with vascular
fibroblast glutaminolytic profiles. Aim 2) Utilize 18F-fluoroglutamine PET imaging to measure glutamine
uptake in SSc-PAH vs. controls. We found increased glutamine uptake into pulmonary vessels and right
ventricle in rodent PAH, as quantified by PET imaging of a 18F-FGln tracer and by spectral (MIMS) imaging of
15N-glutamine. In a first-in-human study, we will investigate 18F-FGln PET/CT in SSc-PAH patients vs. SSc alone
and non-diseased controls. This aim will define the relevance of glutamine metabolism in human SSc-PAH and
the potential of 18F-FGln to serve as a novel diagnostic tracer for SSc-PAH. Significance: Our multi-disciplinary
team is uniquely positioned to define the clinical relevance of a platelet-to-fibroblast metabolism pathway critical
for inducing vascular stiffening and PAH. We will leverage those findings to embark on a first-in-human diagnostic
study of 18F-FGln PET/CT. In sum, we will define the intercellular axes that converge upon platelet and fibroblast
metabolism in SSc-PAH, thus offering much needed targeted diagnostics in this deadly disease.

Public health relevance
In this proposal, we aim to define how cells in the blood vessels in the lung from persons who suffer from systemic sclerosis communicate with each other and promote the development of disease in those blood vessels. In doing so, we will embark on a first-in-human study to define a new imaging technique for better detection of blood vessel disease in lungs. If successful, our work could shape the principles of how blood vessel disease in the lungs develops, offering much needed and more effective ways to detect and treat this deadly condition in systemic sclerosis.